Weinstein Cardiovascular Development and Regeneration Conference

PROJECT SUMMARY
This proposal requests support for the 2023 Weinstein Cardiovascular Development and Regeneration
Conference, which will be held in San Diego, California. The Weinstein Cardiovascular Development and
Regeneration Conference was founded to create an open forum for investigators studying the etiology,
pathology, and eventual treatment of congenital heart diseases (CHDs). This tradition initiated with a series of
annual meetings that brought together investigators who were funded by three separate NIH RFAs on Cardiac
Development; these RFAs, the first of which was issued in 1984, were sponsored by Dr. Constance Weinstein
and her colleagues at the NHLBI. Since its origins, this conference has been the premier opportunity for
researchers in the field of cardiovascular developmental biology to meet and share their data and ideas. During
the 3-day meeting, basic scientists, clinicians, engineers, and geneticists come together to interact and discuss
a multitude of cardiovascular developmental mechanisms and their impact on CHDs, as well as the secondary
outcomes that result in adult cardiac dysfunction. This conference is unique for several reasons. First, it is a
freestanding meeting that is entirely organized by active researchers within the cardiovascular developmental
biology community who are unaffiliated with any society or parent organization. Second, with the exception of
the keynote speakers, all oral platform presentations are chosen from abstracts submitted by early career
faculty, postdoctoral fellows, and graduate students. This approach insures that only cutting-edge data are
shown and avoids repetitive presentations by established investigators selected solely by reputation. Third, this
conference is consistently attended by a substantial number of senior investigators in the cardiovascular
developmental biology field, even though they are not delivering oral presentations and are required to pay for
their own registration and travel expenses. Fourth, the conference community maintains a welcoming and
collaborative atmosphere that encourages sharing of innovative and unpublished data. As in prior iterations of
this conference, the objectives of the 2023 Weinstein Cardiovascular Development and Regeneration
Conference are to promote a collegial environment for dissemination and discussion of innovative and
unpublished scientific findings, to encourage interactions and collaborations among colleagues in the field, and
to enhance the professional development of a diverse array of early career faculty, postdoctoral fellows, and
graduate students by providing a platform for the presentation of their data and an opportunity to network and
interact with established cardiovascular developmental biologists. In this application, financial support is
requested to subsidize registration fees for trainees in order to encourage robust attendance of early career
researchers, to provide financial assistance in the form of travel awards for selected trainees, with a particular
focus on supporting attendance of women, underrepresented groups, and individuals with disabilities, and to
support general conference costs.

Public health relevance
PROJECT NARRATIVE Congenital malformations, or structural birth defects, are the leading cause of infant mortality in the US and Europe, and congenital heart diseases are the most commonly encountered category of congenital malformations, occurring in as many as 1 in 100 live births and 1 in 10 stillbirths in Western nations. The annual Weinstein Cardiovascular Development and Regeneration Conference assembles clinical and basic scientists from around the world to discuss the latest findings regarding the causes of congenital heart diseases as well as novel ideas for potential therapeutic approaches, and this proposal seeks support from the NHLBI for the 2023 Weinstein Cardiovascular Development and Regeneration Conference in San Diego, California.